Neural Stem Cell Based Virotherapy for Malignant Glioma

PROJECT 1: PROJECT SUMMARY
Glioblastoma remains resilient to therapy and recurrence is almost universal. In particular, targeted
therapies fail given the heterogeneity in the expression or presence of molecular targets for these therapies
across tumors. Oncolytic virotherapy (OV) is an anti-tumoral strategy where viruses selectively replicate and
kill tumor cells in the brain and potentially, activate anti-tumoral immune response. Initial studies showed that
a bottleneck for the efficacy of OV was poor distribution of virus in the human brain. To overcome this
challenge, over the last SPORE funding period, we investigated the feasibility and safety of delivering
oncolytic adenovirus to the peri-tumoral brain of malignant glioma patients using neural stem cells (NSC)
which can carry OV, and migrate to distant tumor pockets infiltrating the brain. We conducted a Phase 1 trial
in which we showed the feasibility, safety and established a maximally-tolerated dose for this therapy
(NCT03072134) and published the results in Lancet Oncology. The next step in this program is to perform a
phase II trial to investigate the efficacy of OV using overall survival as an endpoint for efficacy. However, a
phase II trial needs to be optimized via additional studies proposed in this continuation of funding by 1)
enabling multiple injections over time, to be accomplished through a novel brain parenchymal catheter-based
delivery system (Renishaw ®). 2) maximizing NSC viability and OV production using N-acetylcystein Amide
(NACA), which we showed to enhance delivery and efficacy of this therapy, and 3) a priori-identification of
patients with tumors that are susceptible to OV. We hypothesize that only a subset of patients might have
tumors that are susceptible to OV, and that identification of susceptible tumors will allow elucidation of an
efficacy signal. In this continued renewal of Project 1, we now propose the following specific aims:
Specific Aim 1: Conduct a phase 1B expansion trial utilizing a novel catheter method to deliver multiple
injections of product in newly diagnosed malignant gliomas
Specific Aim 2: Examine the pre-existing tumor microenvironment, the effect of NACA on viral replication, and
the immune response during NSC-OV therapy in malignant glioma patients.
Specific Aim 3: Validate genes that are implicated in glioma susceptibility to oncolytic virus using paired
analysis of pre-treatment and during-treatment human glioma specimens

Public health relevance
PROJECT 1: PROJECT NARRATIVE One of the major limitations of oncolytic virotherapy (OV) is poor intratumoral distribution. To overcome this problem our group has demonstrated that neural stem cells (NSCs) can be used as a cell carrier to enhance the delivery of a novel oncolytic adenovirus and increase the therapeutic efficacy of such combined strategy vs. local delivery of the virus alone. In this continued renewal, we focus on establishing the safety of repeat product administration utilizing a novel and implantable based catheter system, examine tumor microenvironment after product administration, and validate previously identified genes implicated in OV susceptibility as a biomarker for patient selection in a larger phase 2 clinical trial.